Modulating Stochastic Gene Expression for Cell-fate Control and Therapeutics

PROJECT SUMMARY
Stochastic fluctuations in gene expression are unavoidable at the single-cell level and affect fate decisions from
HIV to embryonic development. Yet, there remain fundamental gaps in our understanding of the mechanisms
generating and regulating expression fluctuations in mammalian cells. Addressing this gap in knowledge is
critical to therapeutic development in systems where fluctuations and heterogeneity present treatment barriers,
such as in HIV, stem-cell therapeutics, and cancer. Our long-term goal is to develop therapeutics that target
mechanisms of cellular heterogeneity to overcome barriers to precise control of cell fate.
During the past 5 years, our work established mechanistic roles for noise and heterogeneity, demonstrating that
noise is a feature, rather than a bug, of biological systems that can be modulated for therapeutic effect.
Specifically, we: (i) elucidated a viral transcriptional-feedback circuit that harnesses noise to regulate HIV latency,
(ii) found this circuit to be optimized by evolution to function as a viral bet-hedging circuit, (iii) made contributions
to cell biology showing that transcriptional fluctuations are, in general, amplified by nuclear export and translation,
and, (iv) we discovered a novel post-transcriptional feedback architecture that efficiently suppresses noise to
stabilize fate commitment. Most excitingly, and most relevant to this application, we (v) discovered noise-
enhancer molecules that appear to substantially improve viral reactivation from latency and have been used
by other labs to increase noise in diverse systems (e.g., circadian rhythm).
The objective of this renewal is to identify molecular mechanisms of noise modulation in mammalian cell-fate
circuits to enable therapeutic control of noise. Based on our findings and extensive preliminary evidence in
embryonic stem cells (ESCs), our central hypothesis is that generalized `core' cellular mechanisms exist to tune
expression noise and that these mechanisms can be pharmacologically perturbed. Our specific aims build off
our unique tool of noise-enhancer molecules and will: (Aim 1) map the molecular mechanistic pathways of noise
enhancer molecules to develop a mathematical model predictive of transcriptome-wide noise in mammalian
cells; (Aim 2) map the molecular mechanisms of noise-suppressor molecules; and (Aim 3) to quantify relative
contributions of stochastic vs. deterministic mechanisms underlying HIV latency in vivo and safety &
efficacy of noise-modulating molecules in vivo. The proposed research has broad significance as it will determine
core molecular mechanisms regulating expression in disparate fate-specification models, reveal genetic targets
of noise enhancement and suppression that can lead to the development of new broad-spectrum noise
modulators, and propel clinical translation of noise-modulating molecules. Ultimately, the knowledge gained will
guide new therapeutic approaches to overcome barriers to precise cell-fate control across diverse mammalian
systems.

Public health relevance
PROJECT NARRATIVE Stochastic fluctuations in gene expression impact cell-fate specification decisions from embryogenesis to viral infection creating barriers for effective treatment interventions. Based on therapeutic precedents in neuroscience that use fluctuations to improve sensorimotor function, this project will identify centralized molecular and cellular mechanisms of noise modulation, that can be therapeutically targeted, in embryonic stem cells (ESCs). The proposed research will lead to development of new broad-spectrum noise modulators, and propel clinical translation of noise-modulating molecules to guide new therapeutic approaches that overcome barriers to precise cell-fate control in diverse mammalian systems.